Human Thalamus in Propagation of Temporal Lobe Seizures and Memory Formation

PROJECT SUMMARY
The clinical potential of neuromodulation of the anterior nucleus of the thalamus (ANT) in patients with refractory
epilepsy is becoming evident. Nevertheless, this approach exhibits limited effectiveness and, in some patients,
gives rise to unwanted side effects, including memory impairments. Recent preliminary evidence suggests that
other thalamic nuclei may be engaged earlier and more prominently than the ANT during seizure propagation.
To date, however, our understanding of seizure propagation through the human thalamus and the mechanisms
of memory deficits introduced by ANT neuromodulation remains poorly understood. The goal of the proposed
project is to address the existing gaps of knowledge by examining how two key subregions of the human
thalamus (ANT and pulvinar) are connected with other brain structures (Aim 1), how seizures involve the two
thalamic subregions differently and how the map of cortico-thalamic ictal propagation matches the intrinsic
connectivity maps identified in the same individuals (Aim 2). We will also study the spatiotemporal dynamics of
electrophysiological activity within ANT and between ANT and the hippocampus during an experimental
paradigm of memory encoding. By applying direct electrical stimulation of the ANT (using conventional DBS
parameters) we will determine the causal relevance of ANT to different aspects of human memory processing.
Given our track record with intracranial research, we confidently aim to recruit patients with multisite thalamic
recordings to test specific sets of hypotheses. The promise of the proposed project is to create a
comprehensive map of cortico-thalamo-cortical electrophysiological causal effective connections in the human
brain, its concordance with resting state fMRI connectivity, the thalamic routes of propagation for seizures
originating from the temporal lobes, and whether these could be predicted by the resting state fMRI maps. Data
from the memory experiment coupled with causal manipulation of the ANT will provide (hitherto missing)
mechanistic and causal knowledge about the mode of ANT function during memory encoding in the human brain.
Information gathered will be of relevant to future studies investigating the merits of personalizing the thalamic
targets for treating patients suffering from refractory epilepsy.

Public health relevance
NARRATIVE As deep brain stimulation of the thalamus gains traction in the treatment of medication-resistant seizures, a crucial challenge in epilepsy practice revolves around comprehending the propagation of temporal lobe seizures, the most common form of epilepsy, through the brain’s switchboard, i.e., the thalamus, and why and how the neuromodulation of thalamus in patients with epilepsy is associated with memory problems in some but not all patients. This proposed project aims to shed new light on the electrophysiological and functional connectivity of the thalamus with the brain (Aim 1), its mode of involvement during the propagation of temporal lobe seizures (Aim 2), and its interaction with the hippocampus during memory encoding and the effect of DBS in the thalamus on memory processing (Aim 3). Such insights could enhance our understanding of seizure propagation through the thalamus and offer novel perspectives on the neural mechanisms of memory encoding in the human brain.